A novel, orally available small molecule AMPK activator as a treatment for non al

DESCRIPTION (provided by applicant): No specific therapies exist for nonalcoholic steatohepatitis (NASH), which affects 2-5% of Americans. The long term goal of this project is to develop DB0930-007-a novel, highly specific, orally available small molecule activator of 5'-AMP-activated kinase (AMPK)-as an innovative treatment for NASH. Preliminary data indicate that administration of DB0930-007 to mice fed a high fat diet (HFD) reduces hepatic cholesterol, triglycerides, free fatty acids, alanine aminotransferase (ALAT), aspartate aminotransferase (ASAT) and γ-glutamyl transpeptidase (GGT) to control diet levels-importantly with no liver toxicity. The HFD model is, on its own, insufficient for the complete analysis of NASH. Notably, the ability of our compound to reduce NASH inflammation is unknown. Accordingly, the Specific Aims for this Phase I project are: 1) Exploit an improved NASH model to determine if DB0930-007 can reverse the metabolic and fibrotic pathologies of NASH. A streptozotocin/HFD procedure will be used 2) Determine the anti-inflammatory effects of DB0930-007. Biochemical, immunohistochemical and cell biological assays will be employed along with our NASH model. The expected outcome of these studies will be the identification of a potential first in class treatment for NASH, ready for further development to GLP/Tox stage. NASH affects up to 5% of the US population and will increase in prevalence with the obesity pandemic. It has no specific treatment. AMPK activators represent a novel, innovative approach that could revolutionize NASH treatment. AMPK activators would be marketed to treat NASH with potentially few side effects.

Public health relevance
PUBLIC HEALTH RELEVANCE: Nonalcoholic steatohepatitis (NASH) is a form of fatty liver disease that arises from obesity and can result in cirrhosis, liver failure and is a risk factor fo hepatocellular carcinoma (liver cancer). NASH currently afflicts ~10 million people in the United States-a number that will undoubtedly rise with the obesity pandemic. This project seeks to determine if Mercury Therapeutics' novel, orally available drug DB0930-007 is effective against the hepatosteatosis (fatty liver), fibrosis and inflammation associated with this disease-a finding that would make DN0930-007 a first in class effective treatment for NASH.